PATHOGENESIS OF MURINE LUPUS NEPHRITIS

The pathogenetic mechanisms underlying the diverse forms of murine lupus nephritis are being investigated. Renal morphology is being studied by light, immunofluorescence, immunoperoxidase and electron microscopy to delineate the types of glomerular and tubulo-interstitial lesions, as well as the characteristics of the immune deposits and the lymphoid cell proliferation. The impact of provocative maneuvers on serologic and renal histologic features is being examined to develop a model of a flare of lupus nephritis. Innovative treatment strategies will be studied as part of an ongoing effort to refine our approach to this disease.